Role of the pro-inflammatory omental microenvironment in ovarian cancer progression

PROJECT SUMMARY/ABSTRACT
High-grade serous ovarian cancer (HGSC) metastasizes preferentially to the omentum, which is a well-
vascularized fold of peritoneal tissue covered by mesothelial cells and a major site of intra-abdominal fat
accumulation. It was reported that HGSC and stromal cell-derived pro-inflammatory cytokines downregulate
omentin (ITLN1), a novel mesothelial cell-derived adipokine to promote the invasive potential and proliferation
of cancer cells in the omental microenvironment. Omentin has been shown to suppress ovarian cancer invasive
potential and cell growth through suppressing MMP1 expression and cell traction force in cancer cells, and
inducing a local rapid metabolic coupling between ovarian cancer cells and neighboring adipocytes. Besides,
higher levels of pre-operative serum omentin in patients with HGSC were associated with longer survival times.
In addition, mice treated with omentin had marked increase in activated CD8+ T cell density compared to the
untreated control. These findings suggested that adipocytes play an important role in mediating the suppressive
effect of omentin on the malignant phenotype of ovarian cancer cells, and the immune microenvironment.
Therefore, we focus on secretory proteins that can be upregulated by omentin in mature adipocytes. A recent
proteomic study demonstrated that an anti-inflammatory protein tumor necrosis factor-inducible gene 6 protein
(TSG-6) was the top gene upregulated by omentin in adipocytes. Previous studies demonstrated that TSG-6
inhibits infiltration of immune cells during inflammation. It can also bind to specific chemokines such as CXCL12
and prevent them to bind to glycosaminoglycan (GAG)-rich tumor stroma and endothelial cell surface, suggesting
that TSG-6-mediated blockade of these cytokines to suppress tumor growth, angiogenesis, and regulatory T cell
trafficking. Based on these findings, we hypothesize that omentin normalizes the pro-inflammatory omental
microenvironment in ovarian cancer through upregulating anti-inflammatory TSG-6 in adipocytes, which binds to
pro-inflammatory cytokines secreted by cancer cells and various stromal cell types, which attenuate the
immunosuppressive tumor microenvironment, prevent omental metastasis, and suppress tumor progression,
and subsequently improve patients’ survival rate. To test this hypothesis, first, we propose to determine the
roles of omentin in normalizing the immunosuppressive microenvironment and preventing tumor development in
ovarian cancer. Second, we propose to determine the mechanisms by which omentin reprograms the immune
landscape in ovarian tumor tissues and suppresses the invasive potential of ovarian cancer cell. Third, we
propose to determine the efficacy of omentin administration alone or in combination with paclitaxel in ovarian
cancer treatment, and determine the pharmacokinetics/pharmacodynamics and toxicity of omentin using various
mouse models. Our studies will enable us to delineate the immune modulator role of omentin in HGSC
pathogenesis, and to further develop omentin as a chemopreventive and therapeutic agent in the treatment of
HGSC to improve patients’ survival rates.

Public health relevance
PROJECT NARRATIVE The proposed study seeks to demonstrate that the omentin/TSG-6 axis plays a role in normalizing the pro- inflammatory omental microenvironment and preventing ovarian cancer development. This new understanding will enable us to delineate the immune modulator role of omentin in high-grade serous ovarian cancer (HGSC) pathogenesis, and to further develop omentin as low-toxicity chemopreventive and therapeutic agent for HGSC patients, ultimately improving their survival rates. Other prevention strategies that can upregulate omentin, such as weight loss and exercise programs, can also be developed to help prevent cancer metastasis and recurrence.